Cancer Genomics: Integrative and Scalable Solutions in R/Bioconductor

Abstract
Bioconductor is a crucial resource for statistical analysis and data management in cancer genomics research,
providing more than 2,200 open-source software and data packages. This software ecosystem is supported by
core data classes and methods that provide convenient representations and efficient operations for many kinds
of high-throughput omics data. Recent technical advances enable increasingly resolved study of the molecular
biology of cancer at the single-cell level, through combined assaying of DNA sequence, epigenetics, gene
expression, protein, and other aspects, even with spatial information. These developments present new
challenges in the complexity, size, and interpretability of data analysis. The overarching goal of this project is to
maintain and expand the core Bioconductor software infrastructure to meet these challenges, through the
following aims. First, we will maintain and expand infrastructure for multimodal experiments and spatial
transcriptomics, and connect the R/Bioconductor ecosystem with non-R image analysis tools to facilitate
statistical analysis of histopathology images in the context of spatial transcriptomics and other molecular data.
Second, we will transition Bioconductor’s data and annotation-sharing tools to a federated, language-agnostic
system that facilitates contribution and extension by the community, improves findability, enables automated
improvement in metadata, and enhances utility for non-R users. Third, we will create curated and integrated data
repositories that make key datasets more findable and usable, and drive the development of the planned new
data-sharing systems. Finally, we will develop a program of user training and new outreach approaches to
support the training of users and developers, including the creation of a large language model-based chatbot
and a cloud-based platform with persistent disks for courses and workshops. By fostering knowledge
dissemination and practical training, we aim to empower researchers with the necessary skills and resources to
leverage the enhanced capabilities of Bioconductor for advanced cancer genomics research.

Public health relevance
Project Narrative Researchers gather a wide range of complex genetic information in order to comprehend the intricate factors involved in the development and treatment of cancer. This proposal develops, expands, and sustains essential software and data resources that aid cancer researchers in effectively managing and analyzing this information using advanced computational and statistical approaches.